Multi-level school-based intervention to improve HPV vaccine uptake and completion in South Africa

PROJECT SUMMARY
Human Papillomavirus (HPV) is the most common sexually transmitted infection globally, and is causally
linked to cervical, anogenital, and oropharyngeal cancers. HPV-associated cancers have a disproportionate
impact in low-resource settings and nowhere is this evident than in South Africa, which has a uniquely
vulnerable population due to the convergence of the largest HIV epidemic globally, with HPV rates of up to
85% in young women under the age of 25. Cervical cancer is the leading cause of cancer-related mortality
among women in South Africa. In 2014, the South African National Department of Health implemented a
national, school-based HPV immunization program. Despite a promising start, vaccine coverage and dose
completion rates dropped precipitously after 2014, with only 37% of girls receiving their first dose in 2021.
Recent declines have been attributed to COVID-related program interruptions, increased medical mistrust, and
vaccine hesitancy related to misinformation spread on social media. There are additional critical gaps in care –
specifically boys who are ineligible for this program, as well as adolescents outside the public school system.
There is an urgent need to identify effective, replicable, and scalable strategies to optimize HPV vaccine
uptake and completion in school-age children. The overall objective of the proposed R34 is to refine and
evaluate a school-based multi-level communications strategy that addresses intrapersonal, interpersonal, and
institutional factors associated with HPV vaccine uptake and completion amongst fifth graders, as part of a pilot
feasibility trial. The proposed study is led by investigators from the United States and South Africa in
partnership with the Department of Health and elementary schools in an urban setting with high burden of HPV
vaccine preventable cancers in KwaZulu Natal, South African. The project builds upon our team’s expertise in
HPV prevention, vaccine decision making, health communications, participatory design, and community
engagement to pursue the following Specific Aims. (1) To refine components of a school-based multi-level
communication strategy to improve HPV vaccine uptake and completion among girls and boys, and (2)
To evaluate preliminary effects of the communications strategy and key criteria to advance to a full-
scale hybrid type 2 trial. Our systems-focused approach leverages established partnerships with area
schools serving diverse populations who are not always effectively served by traditional healthcare channels.
We will ensure health equity is at the core of our research integrating the voices of individuals living in low-
resource settings to understand and reduce the barriers to HPV vaccine initiation and completion. This
proposal is responsive to NCI’s call for cancer prevention and control clinical trials planning grants (PAR-22-
173) both in its active stakeholder engagement, and its focus on engaging a diverse, scientifically appropriate
study population.

Public health relevance
PROJECT NARRATIVE The proposed study will refine and evaluate components of a school-based multi-level communications strategy that addresses intrapersonal, interpersonal, and institutional factors associated with HPV vaccination uptake and completion. Participatory methods and community engagement are foundational to the approach. Achieving the goals of this project has the potential to inform the South African Integrated School Health Programme regarding effective strategies to promote uptake and completion of HPV vaccine amongst girls and boys and provide an approach that is replicable in other low- and middle-income settings where the burden of HPV-associated cancers is high.